Utah Stimulating Access to Research in Residency

Abstract
University of Utah Health is the only academic health center in the Intermountain West and has a strong
history of knowledge discovery. The proposed Utah Stimulating Access to Research in Residency (Utah
StARR) R38 Program will train resident-investigators in Family Medicine, Internal Medicine, Neurology,
Medical-Pediatrics, Obstetrics and Gynecology, and Pediatrics to become physician scientists working across
a broad spectrum of clinical, translational, community-engaged, and health services research. We will admit
up to four trainees per year. The Utah StARR Program will administratively be housed at the Department of
Family and Preventive Medicine in the UofU Health and will include collaborative efforts from across the four
other participating departments.
The program will include three tracks: 1) Clinical and Translational Research Track; 2) Health Services
Research Track; and 3) Community-Engagement Research Track and will emphasize training in research
methods, career development including scientific writing, and expert faculty mentoring by seasoned NIH and
NHLBI researchers. The program’s research curriculum, mentored research, and career development
activities will lead to success in transitioning resident-investigators to successful careers as clinician-scientists
in primary care-serving and related specialties focused on research targeted to reduce health disparities in
cardiovascular and pulmonary and related diseases impacting disadvantaged populations. It is expected that
by the end of the program resident investigators will be well positioned to apply for early career research
awards, including career development (K-type) awards.

Public health relevance
Project Narrative University of Utah Health will offer the Utah Stimulating Access to Research in Residency (Utah StARR) R38 Program to resident-investigators from six residency programs including Family Medicine, Internal Medicine, Neurology, Medicine-Pediatrics, Obstetrics and Gynecology, and Pediatrics with the goal of transitioning resident-investigators to successful careers as clinician-investigators to conduct clinical, translational, community-engaged, and/or health services research. Trainees will be provided didactic coursework in research methods, leadership training and career development, and extensive mentoring throughout the program. The proposed outcome of the research training program is to increase the number of resident- investigators from primary-care serving and related specialties engaged in research aimed at reducing health disparities in cardiovascular, pulmonary, and related diseases impacting disadvantaged populations.